International Maternal, Adolescent and Pediatric Therapeutics Clinical Trials Network

ABSTRACT
The International Maternal Pediatric Adolescent AIDS Clinical Trials (IMPAACT) Network has significantly
advanced efforts to stem the global HIV epidemic among pregnant women, infants, children and adolescents
through the conduct of high-quality clinical trials. The IMPAACT vision and overall goal is to end the worldwide
HIV epidemic among these vulnerable populations. To achieve this goal, IMPAACT will evaluate novel and
durable treatments for both HIV and TB, to establish strategies for antiretroviral treatment (ART)-free
remission, and to address the complications, co-morbidities, and co-infections affecting these HIV-infected and
at-risk populations of interest. The results of our studies have contributed to licensure or labeling changes for
new antiretrovirals/formulations for use in HIV-infected pregnant women, infants and children and influenced
international and US guidelines for clinical care in these vulnerable populations. In addition to generating
concrete evidence in these areas, IMPAACT's work has served to build much needed research and laboratory
capacity in resource-limited settings, where burden of the HIV epidemic remains the greatest. The IMPAACT
Laboratory Center has been integral to the Network's success in defining the standards of care for HIV infected
pregnant women, children and adolescents. Many of the mechanistic underpinnings that explain the success of
IMPAACT clinical trials are managed and discovered by IMPAACT Laboratory Center investigators. In this
competitive renewal of the IMPAACT Laboratory Center, we propose a work closely the Operations Center and
the Statistical and Data Management Center to develop, implement and evaluate the laboratory activities
necessary to accomplish IMPAACT's research agenda. Further, the Laboratory Center will ensure that there
are relevant state-of-the-art expertise and technologies and to oversee all laboratory operations confirming that
all laboratory results are consistent, reproducible and can support study reconstruction.

Public health relevance
NARRATIVE The Laboratory Center will provide laboratory-based scientific leadership, consultation and laboratory capacity, to enhance IMPAACT's Research Agenda and achieve its Scientific Aims. It will also provide the technical, regulatory and administrative infrastructure and oversight for all laboratory testing done in support of IMPAACT clinical trials.